Role of Adaptive Immunity in Lung Cancer Response to Oncogene-targeted Therapeutics

PROJECT SUMMARY. Lung adenocarcinomas (LUAD) driven by oncogenic receptor tyrosine kinases (RTKs),
including mutant EGFR and ALK, ROS1 and RET fusion proteins represent ~25% of LUAD and exhibit
impressive responses to precision targeted tyrosine kinase inhibitors (TKIs). However, significant heterogeneity
in response to TKI therapy exists between patients as manifested by variation in depth of response (DepOR),
characterized as “residual disease” burden, as well as the duration of the therapeutic response (i.e., time to
progression (TTP) or progression-free survival (PFS)). A deep cellular and molecular understanding of the
variation in TKI responsiveness among oncogene-driven LUAD subsets is predicted to inform novel pathways
that may be manipulated for therapeutic gain in these cancers. Inhibitors of the PD1/PD-L1-axis are now integral
to lung cancer treatment, but are ineffective in subsets of LUAD driven by oncogenic RTKs, even when PD-L1
positive. Based on their lack of response to immunotherapies and lower mutation burden, it is tempting to
consider host immunity as irrelevant to RTK-driven LUAD subsets and the therapeutic actions of TKIs. However,
our published and preliminary findings and an emerging literature demonstrate that host immune cells are
significant contributors to the therapeutic benefit of precision oncology agents. We reported that EGFR-targeted
TKIs induce an interferon gamma (IFN) transcriptional response program as well as increased T cell signatures,
both of which positively associate with longer TTP in EGFR-mutant LUAD patients. Moreover, studies with
pretreatment biopsies from ALK+ lung tumors reveal an association of myeloid cell-neutrophil content and
shortened PFS. Finally, using novel murine orthotopic models of EGFR and ALK+ LUAD, we demonstrate that
the durability of TKI therapeutic responses requires adaptive immunity. The precise role of adaptive and innate
immune cells in oncogene-targeted drug action represents a significant knowledge gap.
The proposed studies will use pretreatment and on-treatment lung cancer patient specimens and innovative
orthotopic immunocompetent models driven by oncogenic EGFR, ALK and RET to explore how TKIs alter the
immune microenvironment to regulate therapeutic response. Findings from syngeneic immunocompetent
C57BL/6 hosts reveal pronounced and durable tumor shrinkage responses to TKIs, but reduced DepOR and
rapid progression on continuous treatment when propagated in immune-deficient mice, revealing a critical role
for adaptive immunity. Our proposed studies will address two major knowledge gaps: 1) How does the
composition of the tumor microenvironment (TME), both before and on-treatment, influence the DepOR and
TTP? 2) What are the specific chemokine pathways and immune cell types that positively and negatively
contribute to therapeutic responsiveness? We hypothesize that the observed TKI responses in RTK-driven lung
tumors represent integration of direct TKI growth inhibitory inputs plus varying participation of anti-cancer T cells
and immune-suppressive neutrophils dictated by CXCL9/10 and CXCL1/2 chemokine pathways. To test this
hypothesis, these specific aims will be completed. Aim 1. Define immune cell content in EGFR, ALK, ROS1 and
RET+ patient specimens and test the association with clinical response (TTP, DepOR). Aim 2. Use orthotopic
murine EGFR, ALK and RET+ tumor models to define specific immune cell types that positively and negatively
contribute to the overall TKI therapeutic response. Aim 3. Specific chemokine pathways as mediators of the
baseline and TKI-regulated immune microenvironment will be defined.

Public health relevance
Lung adenocarcinoma (LUAD), a tobacco-related malignancy, also occurs in never smokers and is over- represented in veterans. Application of precision oncology with tyrosine kinase inhibitors (TKIs) in patients whose tumors bear oncogenic EGFR, ALK, ROS1 and RET yields frequent tumor shrinkage, but with wide variation in the treatment duration. Importantly, acquired drug resistance drives almost universal treatment failure. We propose that the therapeutic responses to TKIs involves induction of tumor-derived signals that instruct participation of both anti- and pro-tumorigenic immune cells. This project uses novel murine models of EGFR, ALK and RET-driven LUAD to identify tumor-derived signals and host immune cells that contribute to the TKI response. Also, pretreatment tumor specimens from patients will be analyzed for specific immune cells that predict the duration of response. Completion of the project may inform mechanisms regulating varied duration of patient benefit and potentially, novel vulnerabilities to increase duration of patient benefit from TKIs in LUAD.